Subcellular Origins of Extensive Spatial Integration by Ganglion Cell Photoreceptors

PROJECT SUMMARY/ABSTRACT
When faced with a visual scene, the brain encodes both image detail and the scene’s overall intensity,
measured as irradiance. Encoding irradiance is critical for circadian regulation, pupil constriction, and image
vision, among other important functions. A canonical feature of irradiance encoding is the blurring of image
detail in favor of extensive spatial integration of light. The cells in the retina that transmit irradiance information
to the brain are the intrinsically photosensitive retinal ganglion cells (ipRGCs). My goal is to understand how
the mechanisms of phototransduction in the ipRGCs support this spatial integration. Melanopsin, the light-
sensitive protein in ipRGCs, is distributed throughout the dendrites, soma, and axon. IpRGCs send irradiance
information to the brain using spikes and phototransduction within the axon is likely to shape spike output.
Preliminary experiments indicate that ipRGC axons are indeed photosensitive. In mice, melanopsin
immunostaining labels axons, including at the optic disk. In electrophysiological recordings of mouse ipRGCs,
illumination of the axon evokes spiking responses, and the cells are more sensitive to large stimuli that
illuminate their axons in addition to their somas and dendrites. I hypothesize that phototransduction in the axon
enables the spatial integration of light over an unexpectedly large area. The lab has established protocols for
electrophysiological recordings from the soma and axon of ipRGCs, and for imaging visually-evoked Ca2+
dynamics in the population of ipRGC axon terminals. I propose an investigation into mechanisms of axonal
photosensitivity (Aim 1) and the axonal contribution to spatial integration at the level of the cell population (Aim
2). To complement my investigations in the mouse, I will also measure the properties of ipRGCs in a species
that has larger eyes and thus longer axons. My proposed experiments will provide an understanding of how
signal transduction operates in distinct cellular compartments of a sensory neuron to support spatial
integration.

Public health relevance
PROJECT NARRATIVE This project concerns spatial integration of light by a ganglion cell photoreceptor that connects the eye to the brain and senses light to drive the often-subconscious effects of light on physiology and behavior. The proposed experiments will define how phototransduction is integrated across the photoreceptor cell’s subcellular compartments and how spatial integration emerges at the population level, providing insights that are likely to generalize to other types of sensory neurons. The knowledge gained in this project will be important for developing therapeutics that compensate for disruptions in light’s regulation of critical functions like circadian rhythms, mood, and sleep.